New roles for Topoisomerase II in meiosis

PROJECT SUMMARY/ABSTRACT
Haploid gametes (i.e. eggs and sperm) are generated from diploid precursors through the cell division of
meiosis. Eggs and sperm are highly specialized cells that differ in both their morphologies and in their
contributions to fertilization and embryogenesis. To achieve these differences, eggs and sperm are generated
from meiotic programs with sex-specific characteristics. However, surprisingly little is known about the
molecular mechanisms that define sex-specificity. Previously, we identified a novel allele of C. elegans
topoisomerase II that uniquely disrupts the segregation of homologous chromosomes during the meiotic
divisions of spermatogenesis but not oogenesis. Topoisomerase II (Topo II) is an enzyme that plays a crucial
role in chromosome fidelity by disentangling topological problems that arise in double stranded DNA. Topo II is
a large ATP-dependent, homodimeric enzyme. Each subunit breaks one DNA strand, passes a second
unbroken strand through the break, and then reseals the break. Thus, Topo II enzymes solve topological
problems that arise during replication, transcription, chromosome segregation, and recombination. The
identification of a sex-specific role for this key, ubiquitous enzyme highlights the differential regulation of the
two meiotic programs. Our long-term goal is to understand the molecules and systems that ensure that each
egg and sperm receive the correct number of chromosomes during meiosis. To understand this fundamental
process, we will utilize the metazoan animal model C. elegans, which, in addition to sexually dimorphic meiotic
programs, provides many experimental advantages such as a fast generation time, a transparent body for in
vivo analysis of meiosis, and a single top-2 gene. The research in this proposal encompasses two main
programs related to sex-specific regulation of meiotic chromosome structure and segregation. Program 1 will
identify sex-specific differences in chromosomal axes components, synaptonemal complex (SC) disassembly,
and chromosome compaction prior to the segregation of homologous chromosomes during the first meiotic
division. Using a targeted candidate gene approach and mutational analysis, including our previously identified
sex-specific top-2 allele, we will identify genes that differentially regulate SC disassembly and chromosome
compaction in spermatogenesis and oogenesis. Then, in Program 2, we delve into the mechanisms that
regulate TOP-2 localization and activity in spermatogenesis and oogenesis. This work builds on our findings
that mutations within tyrosyl DNA phosphodiesterase 2 (TDPT-1) can suppress the top-2 mutant phenotypes.
Using a combination of biochemical and genetic techniques we will identify the mechanism of suppression of
top-2(it7) embryonic lethality for the tdpt-1 mutant suppressors and identify novel TOP-2 interacting proteins
during mitosis vs. meiosis and in spermatogenesis vs. oogenesis.

Public health relevance
PROJECT NARRATIVE The formation of sperm and eggs with the “wrong” number of chromosomes is a key contributing factor to infertility, miscarriages, and birth defects in humans. The proposed project seeks to identify and characterize the mechanisms that contribute to sex-specific chromosome structure and chromosome separation in sperm vs. eggs. The completion of this project will advance our understanding of how the disruption of components that determine chromosome structure and separation contributes to both male and female infertility and to the development of birth defects.